Admin Core: Administration, Biostatistics and Data Coordinating Center

CORE 1 ABSTRACT
The Administration, Biostatistics and Clinical Database Core provides support for all three projects within
the P01. The PI, Dr. Ferrara, is responsible for the overall conduct of this research program. An executive
committee of members (the three project and core leaders) is chaired by the PI. The executive committee
meets formally on a monthly basis to review progress of the individual projects, to monitor the function of
the cores, and to resolve any potential logistical difficulties. Umut Özbek, Ph.D., provides biostatistical
oversight to all projects with expertise in three categories of statistical services: 1) statistical analysis of
clinical and biomarker data; 2) experimental design, sample size calculations and analyses in
experimental models; and 3) clinical trial design and monitoring. Dr. Levine oversees the activities of the
data coordinating center which provides a number of innovative and cost effective services. The MAGIC
database currently contains data for 5,000 HCT recipients and 2300 acute GVHD cases; ~700 patients
(300 with GVHD) per year. This core has developed rigorous processes to minimize data errors both
before and after data entry.
The Core 1 objectives are as follows:
1. To provide administrative and fiscal oversight to all projects and cores, and to facilitate optimal
interactions including centralized data sharing, document generation, organization monitoring,
financial reports, and accountability to all internal and external agencies.
2. To provide advanced biostatistical support for analysis of clinical and laboratory data and assist in
the biostatistical design of experiments in all projects.
3. To oversee the creation and curation of the MAGIC database.

Public health relevance
CORE 1 NARRATIVE Allogeneic hematopoietic stem cell transplantation is a potentially curative therapy for many malignant diseases whose applicability has been impeded by the development of its most serious complication, GI GVHD. Strategies that strengthen the target cells in the GI tract will allow for better harnessing of this effective therapeutic modality. Core 1 contains the administrative, biostatistical support and database operations support for all three projects.